DEVELOPING AND IMPROVING INSTITUTIONAL ANIMAL RESOURCES

The Masonic Medical Research Laboratory (MMRL) was constructed in 1959 to provide a clinical setting for the study of gerontology, a mandate that was abandoned in 1960 in favor of studies in basic biomedical research. Although no clinical studies were ever done the construction and design of the now designated animal facilities reflect their original intent for patient occupancy and for offices. Provisions for animal housing, including appropriate controls for heat and ventilation to meet the needs of advancements in scientific animal care to meet the requirements of federal and state agencies were not made in the original construction. In the intervening 25 years the MMRL has met these by numerous modifications, and restrictions in the capacity to house and use animals, often at the expense of the interests of the investigators using the research facility. These modifications have now reached the limit to correct the deficiencies. The research interacts of the staff and their ability to compete nationally for research funds has been handicapped as a result of these shortcomings. Recent investigator and conceptual changes in areas of their research interest (particularly in microbiology and ageing research) makes it necessary to update and re-equip our animal facility, particularly that part which concerns the rodent areas which not only need better heat and ventilation controls but also for control of their microenvironment. This proposal would provide for a renovation of the heat and ventilation system as well as for equipment and barrier spaces for the housing of the mice and rat population.